Linking Spatial Variations in Shear Stress with Oxidation Stress

DESCRIPTION (provided by applicant): Fluid shear stress imparts both metabolic and mechanical effects on vascular endothelial function. The spatial ( D/ x) and temporal ( D/ t) components of shear stress largely determine the focal nature of vascular oxidative stress, leading to pro-inflammatory states. The focus of the previous grant period was a paradigm shift in the approach from one of the static models (oxidative biology) to the dynamic models of investigation (vascular oxidative stress) that combined biophysical and biochemical approaches of pathophysiological significance. We demonstrated that variations in D/ x and D/ t differentially regulated the endothelial production of O2.- and .NO, leading to low density lipoprotein (LDL) oxidative modifications relevant for the initiation of atherosclerotic lesions. We developed microelectromechanical systems (MEMS) sensors to measure in real-time intravascular shear stress in the New Zealand White (NZW) rabbits on a hypercholesterolemic diet, and applied our intravascular methodology to the swine model. We gained new insights into the mechanisms whereby atheroprotective hemodynamics increased mitochondrial membrane potential ( (m) accompanied by a decrease in mitochondrial O2.- production via an up-regulation in Mn-SOD activities. In contrast, atherogenic hemodynamics and oxidized LDL induced mitochondrial O2.- production, leading to apoptosis via c-Jun NH2 terminal kinase (JNK)-induced Mn-SOD ubiquitination and protein degradation. Our finding led to a novel observation that active lipid and macrophages in the vessel wall cause electrochemical modifications that can be measured by electrochemical impedance spectroscopy (EIS). In this context, we hypothesize that shear stress regulates mitochondrial redox status, modulating vascular oxidative stress to cause distinct changes in electrochemical impedance in regions of non-obstructive, albeit inflammatory lesions. In the new Aim 1, we will provide an ex vivo model of EIS;specifically, the frequency-dependent electrical and dielectrical properties between concentric bipolar microelectrodes and endoluminal surface of explants of human arteries and NZW rabbit aortas. In Aim 2, we will establish an in vivo model of EIS measurements using fat-fed NZW rabbits;specifically, microfabrication and deployment of the electrodes for intravascular EIS measurements. In Aim 3, we will provide molecular and genetic models to demonstrate redox signaling as a requite factor underlying changes in electrochemical modifications. The focus in the next grant period will integrate electrochemical, redox signaling, and genetic approaches to establish specific EIS that occur in response to local pro- inflammatory states during angiograms with the possibility of identifying unstable plaque. In summary, the publication record (30 corresponding authors) of our laboratory in the previous funding cycle is a testimony of our commitment and productivity in mechanobiology and vascular oxidative stress research. PUBLIC HEALTH RELEVANCE: Atherosclerosis is a systemic disease;however, its manifestations tend to be focal and eccentric. We have developed an electrochemical approach to assess LDL oxidation and foam cells in the vessel wall as quantified by electrochemical impedance spectroscopy (EIS). The focus for the next cycle will integrate electrochemical, redox signaling, and genetic approaches to establish specific EIS that occur in response to local pro- inflammatory states with the possibility of identifying unstable plaque when patients undergo angiograms.

Public health relevance
Atherosclerosis is a systemic disease; however, its manifestations tend to be focal and eccentric. We have developed an electrochemical approach to assess LDL oxidation and foam cells in the vessel wall as quantified by electrochemical impedance spectroscopy (EIS). The focus for the next cycle will integrate electrochemical, redox signaling, and genetic approaches to establish specific EIS that occur in response to local pro- inflammatory states with the possibility of identifying unstable plaque when patients undergo angiograms.